2024 Neuroelectronic Interfaces Gordon Research Conferences and Gordon Research Seminar

Abstract
We are requesting support for the 2024 GRC on Neuroelectronic Interfaces: Advances and Challenges in
Neurotech Development and Translation, and the associated GRS, which will be held March 9th – March
15th, 2024, at the Grand Galvez, 2024 Seawall Boulevard, Galveston, TX. Following the successful
2022 Neuroelectronic Interfaces Gordon Research Conference, this proposed conference will continue to
bring together world-class clinicians, scientists, and engineers with a multi-disciplinary skillset (e.g.,
cellular and system neuroscience, neuropathology, neurotechnology, materials science, and engineering),
to share advances, describe challenges, and discuss possible solutions that could support the successful
translation of chronically useful and reliable neural interfaces.
The expectation for Gordon Research Conferences is that vigorous formal and informal discussions will be
maximized between prominent investigators and junior attendees of the conferences, with particular
emphasis being placed on underrepresented groups, women, minorities, and persons with disabilities. This
conference is designed to bridge the scientific field by attracting established researchers, who provide a
strong foundational support for past research, and both outside investigators and junior members of the
field, who often inject new ideas. We intend to prioritize the use of NIH funds to support the participation of
underrepresented participants as well as those experiencing hardship within their research efforts.
Specifically, we will use these funds to cover a portion of the costs of their participation (e.g., registration,
travel, childcare). Thus, we will promote the development of and continued involvement of qualified
researchers from underrepresented groups in neural-engineering research. Additionally, the 2024
conference program has an impressive range of topics, and the speakers are both diverse and of high
quality. We are building a program that we are confident will lead to a lively and inspiring conference that is
at the cutting edge of science and engineering. The program covers important topics related to the
development and translation of Neuroelectronic Interface technologies, ranging from neurotechnology in
society, advances in neuroscience research, interface hardware (from electrodes through packaging), CNS
and PNS targets, non-electrical interfaces, and even non-invasive interfaces. This GRC will provide a
forum for the findings of established scientists engaged in other biomedical areas to enable identification of
new concepts for, and potential collaboration in, neural interfaces research.
We expect this event to continue being a “go to meeting” for the neural interfacing community and
maintaining the tradition and prestige of the Gordon Research Conferences.

Public health relevance
Project Narrative Implants based on neuroelectronic interfaces, which are central to the treatment of many neurological diseases or injuries and can be used to record and/or stimulate neural activity, are quickly becoming the fastest growing sector of biomedical devices. Despite significant initial successes, various challenges exist with the development and translation of neuroelectronic interfaces for some clinical indications. The proposed conference will support the ability of the international community to come together in partnership to develop multidisciplinary solutions that benefit society.